New England Regional Coordinating Center for the NINDS Stroke Trials Network

We propose to continue the New England Regional Coordinating Center (NERCC), an integrated team of
hospitals and EMS agencies in Boston and Western Massachusetts that will serve as a top-enrolling site and
vibrant contributor to the NINDS Stroke Trials Network. Our group includes many of the major adult academic
stroke centers in the Greater Boston area, and our 30+ hospital New England TeleStroke referral network will
extend our potential recruitment even further. All core hospitals have a proven track record of successful
management and performance of clinical trials. In particular, all hospitals have an established research
infrastructure that performs ongoing clinical research in stroke neurology with strong collaborations across
disciplines. Principal investigator Lee H. Schwamm, MD, and Co-Investigators bring a complementary set of
skills in managing successful translational clinical research programs, membership on Steering Committees,
and positions of national leadership in their fields. Our team includes seasoned clinical investigators in vascular
neurology, emergency medicine, neuroendovascular, neurosurgery, neurointensive care, neuroimaging, stroke
rehabilitation, and preclinical basic and translational stroke investigation in both adults and children. Strengths
of the NERCC team include 1) close personal and professional ties between multiple investigators; 2) large
patient population from diverse hospital settings in a major metropolitan area; 3) talented teams of site
investigators with track records of scientific achievement, innovation, and subject recruitment in multicenter
trials; 4) robust existing NINDS-funded research and clinical trial management infrastructure; 5) existing clinical
research programs, e.g., Neurology Clinical Research Institute, NIH Clinical and Translational Science Award
programs at Boston University and across Harvard; Sites in the SIREN and NeuroNEXT Clinical Coordinating
Center. Overall, the NERCC Team has demonstrated outstanding commitment and performance in the first
StrokeNet cycle, and has the resources, vision, and enthusiasm to continue to develop new translational
science and successfully execute the NINDS StrokeNet Phase 1,2 and 3 trials.

Public health relevance
The NERCC will continue to include Massachusetts General Hospital (MGH), Brigham & Women's Hospital (BWH), Beth Israel Deaconess Medical Center (BIDMC), Boston Medical Center (BMC), Tufts Medical Center (TMC), University of Massachusetts Memorial Medical Center (UMMMC), Spaulding Rehabilitation Hospital Network (SRH) and Boston Children's Hospital (BCH), all organizations with internationally recognized patient care and clinical research programs. In the next cycle, we will seek to add Eastern Maine Medical Center.